Understanding output circuits of the lateral entorhinal cortex

Abstract
The entorhinal cortex (EC) and the hippocampus are the brain areas which are critically involved in the formation
and retrieval of declarative memory, and damage to this circuit results in memory impairment. In order to cure
dementias, including Alzheimer’s disease which currently affects 6 million people in the United States, it is critical
to forward an understanding of the cellular and circuit mechanisms involved in the encoding and retrieval of
memory in this entorhinal-hippocampal circuit. The EC is anatomically segregated into two halves, the lateral
entorhinal cortex (LEC), and the medial entorhinal cortex (MEC). Although previous studies have significantly
advanced our understanding of the functional role of the MEC in spatial memory and navigation, our
understanding of the functions of the LEC remains largely unclear. Here we propose studies to investigate the
function of the output layers of LEC in associative memory to address this critical gap in knowledge. Our
approach involves multi-faceted analytical methods including in vivo electrophysiology, associative learning
tasks, optogenetic circuit analysis methods and transgenic mouse lines that express Cre under the promoter of
cell-type-specific markers. There are three Specific Aims to the studies: (Aim 1) identify the roles of serotonin
inputs to LEC layer 5/6 neurons in associative learning; (Aim 2) identify the role of superficial and deep layers of
target regions of LEC layer 5/6, and (Aim 3) determine oscillation mechanisms for interactions between LEC
layer 5/6 neurons and neurons in target regions. If successful, our studies will identify the circuit mechanisms for
associative memory formation in the LEC and will help establish new frameworks for understanding how the
entorhinal-cortical circuit enables the formation of declarative memory via the integration of multiple dimensions
of sensory information.

Public health relevance
Project narrative This proposed research is relevant to public health because discovering the underlying circuit and network mechanisms in associative memory formation and retrieval will forward the understanding of the pathogenesis of memory dysfunctions such as Alzheimer’s disease. Results from this project are expected to help establish new frameworks for understanding how the entorhinal-cortical memory circuit enables the formation of declarative memory via the integration of multiple dimensions of sensory information.